Administrative Core

Project Summary Administrative Core (AC)
The Greater Saint Louis (STL) region and Missouri face a critical turning point in their response to the HIV
epidemic, grappling with approximately 500 new HIV diagnoses and 200 deaths each year, with half of these
occurring in STL. Factors such as poverty, housing issues, co-infections, and drug use exacerbate the
situation, while limited public health investments impede progress, with only 65% of diagnosed individuals
achieving suppression and insufficient PrEP usage. However, there is newfound momentum to combat the
epidemic, as Missouri is among the prioritized "End the HIV Epidemic" states, receiving increased attention
and funding. Washington University in St. Louis (WashU) and Saint Louis University (SLU) can play a crucial
role in advancing the scientific response to HIV. Over the past five years, our HIV funded research has grown
by 80%, and a dedicated group of young researchers and emerging investigators are ready to drive scientific
advancements, engage institutional and community stakeholders, and elevate science's role in our response.
To capitalize on existing resources and enhance the HIV response, we aim to secure an NIH investment for a
Midwest Developmental Center for AIDS Research (D-CFAR). The Administrative Core (AC) will serve as the
central hub of this D-CFAR, ensuring efficient operations, leading stakeholder engagement, and overseeing
monitoring, evaluation, and strategic planning. The AC will be co-led by experienced HIV researchers, Drs.
Geng (WashU) and Iwelunmor (SLU), bridging perspectives from both institutions and ensuring mutual
contributions and benefits. The MPIs have a proven track record of collaboration and a plan for shared
leadership. The AC will effectively implement the Center's objectives by coordinating with other cores and the
Internal Advisory Committee (IAC). The Stakeholder and Community Advisory Committee (SAC) will provide
governance and align the D-CFAR with regional and NIH priorities. The AC's specific aims are to provide
leadership and management for advancing HIV/AIDS research through agile methods, engage regional
stakeholders to align D-CFAR activities with local efforts, and conduct rapid evaluations to ensure effective
implementation and optimal impact, guided by the Translational Science Benefits Model (TSBM). With a robust
administrative infrastructure, the AC will ensure rigorous and efficient communication, operations, engagement,
and evaluation. Serving as the "nerve center" of efforts to improve HIV research and leverage regional
endeavors, the AC will play a vital role in the D-CFAR's contribution to ending the HIV epidemic in the Greater
Saint Louis region and Missouri.